Administrative Core

ADMINISTRATIVE CORE: PROJECT SUMMARY
The Administrative Core is led by Center Director Ramnik Xavier and Associate Directors Atul Bhan, Andrew
Chan, and Mark Daly. The activities of the Administrative Core serve to support the Center’s goals of promoting
interactions among scientists exploring diverse fields that share relevance to IBD, attracting investigators to the
study of IBD, and providing an environment and mechanism to foster development of young investigators
focused on IBD. We believe all these goals are achieved through the seamless coordination of the Center’s
scientific, educational, and technical resources provided via the organizational framework of the Core. The
administrative structure of the Center includes four committees – the Administrative, Executive Steering, External
Advisory, and Institutional Advisory Committees – that facilitate the aims of the CSIBD and provide a mechanism
to respond to Center needs.
The specific aims of the Administrative Core are to (1) grow and diversify the CSIBD research base by actively
engaging new members with methods and specialties relevant to IBD; (2) facilitate and provide oversight of the
Pilot and Feasibility Program; (3) coordinate a multifaceted Enrichment Program; (4) identify, help develop,
disseminate, and promote tools, technologies, and collaborations; (5) convene the associated committees to
support the director in general, administrative, and scientific decisions concerning the CSIBD; and (6)
communicate activities, news, and opportunities through many venues, including the website, within the Center
and to other Digestive Diseases Research Core Centers, NIDDK, and appropriate individuals, groups, and/or
organizations to facilitate collaboration and cross-learnings. The Administrative Core also manages the
collaborative program between the CSIBD and the Broad Institute, which includes Core Enhancement grants
that enable access to Broad Institute-based platforms.